PERFORMANCE OF PROTOCOL TOXICOLOGY STUDIES

Provide for a Prime Contractor to establish and monitor a subcontractor network necessary to perform preclinical toxicology studies suitable for Investigational New Drug Application filing with the Food and Drug Administration.